Acoustic Tweezing Cytometry for Efficient Neural Differentiation

Project Summary
Acoustic Tweezing Cytometry for Efficient Neural Differentiation
Human pluripotent stem cells (hPSCs) have been hailed as a promising cell source for treating degenerative,
malignant, and genetic diseases, or injuries due to inflammation, infection, and trauma. hPSCs have also been
proven as an invaluable discovery tool to study human development and for developing and testing new drugs.
However, to fully realize the tremendous potential of hPSCs, the first and perhaps the most critical step is the
directed differentiation of hPSCs to specific functional cell types with high efficiency and purity.
Motor neurons (MNs) are a specialized class of neurons that reside in the spinal cord and project axons
to muscles to control their activity. MNs are damaged in diseases such as spinal cord injury, amyotrophic
lateral sclerosis (ALS) and spinal muscular atrophy (SMA). While there are significant interests in
differentiating hPSCs into functional MNs for cell therapies and understanding of MN degenerative diseases,
poorly defined culture conditions and inefficient protocols of MN differentiation from hPSCs have significantly
hindered their broad use. Given that embryonic development is a dynamic process involving constantly
changing physical environments, the central hypothesis of this proposed research is that hPSCs, which is
equivalent to the epiblast in the peri-implantation human embryo, are intrinsically mechanosensitive, and
biophysical cues in the cell microenvironment can provide potent regulatory signals to control their
differentiation and functional maturation towards specific neuronal subtypes such as MNs. This proposal is
strongly motivated by our exciting preliminary data showing that a novel ultrasound-based technology, acoustic
tweezing cytometry (ATC), which can apply controlled dynamic subcellular mechanical forces to hPSCs, can
indeed elicit neuroepithelial and even MN differentiation of hPSCs much more rapidly compared to
conventional protocols that solely rely on soluble factors. Thus we propose in this research to fully develop the
ATC technology to not only elucidate the intrinsic mechanosensitive properties of hPSCs, but also utilize the
technology to improve large-scale production of functional MNs.
In this research we propose to (Aim 1) develop high-throughput ATC technology with improved
capability for mechanical stimulation of hPSCs; (Aim 2) elucidate the role of a regulatory network comprising
mechanosensitive pathways (BMP/YAP activity, RhoA/ROCK/cytoskeleton contractility, and Hippo/LATS) in
regulating ATC-facilitated neuroepithelial differentiation of hPSCs; (Aim 3) apply ATC for high-efficiency
functional MN generation from hPSCs. Successful completion of this research will establish a new, novel
approach for hPSC neural differentiation and MN generation, potentially enabling drastic advances in large-
scale production of clinical-grade MNs for cell-based therapies and drug screens. Our proposed research will
also help establish a novel mechanistic framework for understanding mechanosensitive hPSC properties and
will chart a path to unravel their full complexity for their future regenerative medicine applications.

Public health relevance
Public Health Relevance Statement The promise of human pluripotent stem cells as a research and therapeutic tool is critically hinged on efficient culture protocols that can promote directed differentiation of these cells towards different adult cell types with high yield and purity. This research will develop and implement new technologies to investigate how the mechanical signals in the pluripotent stem cell culture can be utilized to improve their differentiation efficiency towards functional motor neurons, loss of which is associated with spinal cord injury, amyotrophic lateral sclerosis, and spinal muscular atrophy. Our research can potentially enable drastic advances in large-scale production of functional motor neurons and thus contribute significantly to future motor neuron-based regenerative therapies and drug and toxicology screens.